Systemic Sustained Release Delivery of Antiretroviral Agents for HIV Prevention

ABSTRACT
New HIV infection rates far outpace the targets set by global health organizations, despite important progress
in curbing the progression of the epidemic. In 2017, an estimated 1.8 million people became newly HIV
infected globally. New HIV pre-exposure prophylaxis (PrEP) strategies are needed urgently to overcome this
alarming prevention gap. Adherence to daily dosing regimens has emerged as a critical factor driving the
clinical success of HIV-1 PrEP with antiretroviral (ARV) drugs in susceptible, uninfected individuals. This
challenge can be mitigated with sustained release or “long-acting” ARV formulations that reduce dosing
frequency, ideally to intervals of once per month or longer, and target the heterogeneous populations most at
risk from contracting HIV. Several ARV drugs are undergoing clinical evaluation as injectable sustained release
formulations, but suffer from a number of drawbacks: a high initial concentration burst; the particles cannot be
removed following injection should there be an adverse reaction; the approach requires specific ARV
physiochemical characteristics, dramatically limiting the range of candidate drugs. Multiple large-scale clinical
trials have shown that PrEP using oral preparations of the nucleoside reverse transcriptase inhibitor (NRTI)
tenofovir (TFV) can prevent HIV-1 infection in a significant proportion of individuals. A long-acting TFV
formulation for systemic dosing would add a much-needed NRTI to the portfolio of sustained release PrEP
options. Under previous NIH support we have developed a subdermal implant delivering the highly potent
prodrug TFV alafenamide (TAF). We have evaluated the pharmacokinetics (PKs) and safety of prototype
implants delivering TAF over a wide range of release rates in mice, beagle dogs, and sheep. The devices were
safe in the target dosing window and allowed us to simulate a human dose for HIV-1 PrEP. The proposed
efforts build on these important accomplishments and will test the central hypothesis that a one-year TAF
implant with practical physical dimensions can safely prevent sexual HIV-1 infection. In Aim 1, we will design
the next generation TAF implant to maximize drug loading and control of drug release using scalable
processes and acceptable biomedical materials. We will conduct PK studies in rats and sheep to help select
lead candidates for extensive safety assessment in sheep under Aim 2. Here, the implant materials and
excipients will be evaluated to maximize local tolerance in vivo, including using innovative targeted
proteomic/metabolomic and non-invasive imaging methods. In Aim 3, HIV-1 (SHIV) prevention efficacy studies
will be carried out in rhesus macaques using repeat low dose rectal, vaginal, and penile exposure models. The
PK-pharmacodynamic relationships will be investigated in exploratory models. The project will advance our
scientific knowledge on the pharmacologic properties of sustained release systemic TAF and its metabolites
compared with oral formulations in the context of HIV-1 prevention.

Public health relevance
PROJECT NARRATIVE Current HIV prevention strategies that require daily oral dosing are burdensome to the user and, consequently, are often not followed. We will use state-of-the-art chemistry and pharmacology research to build on our successes and continue the development of a long-acting, one-year implant for sexual HIV prophylaxis. The proposed research is relevant to public health because it will lead to a rigorous, mechanistic understanding of the innovative devices' mode of action, protect all the relevant anatomic sites, and significantly improve clinical practice for HIV prevention and, possibly, treatment.